Rapid structure-based software to enhance antibody affinity and developability for high-throughput screening: Aiming toward total in silico design of antibodies

Therapeutic monoclonal antibodies bind to specific regions of proteins called epitopes, which elicit cellular
responses that treat or cure disease. Discovering therapeutic antibodies traditionally requires costly and labor-
intensive, laboratory-based screening experiments. Computational approaches that select antibodies with the
most desirable pharmaceutical properties are thus poised to improve health by accelerating the development of
new drugs. Unfortunately, current algorithms are often unable to distinguish stronger-binding antibodies from
weaker ones. Improvements to structure prediction and molecular visualization will lower costs and increase the
speed with which new drugs are developed by allowing researchers to focus on the most promising candidates
as early in the process as possible.
DNASTAR’s goals are to increase the speed of predicting the structure of antibody-antigen interactions using
superior mathematical methods and to transform antibodies with micromolar binding affinity into those with
improved nanomolar affinity using new computer-aided antibody design techniques. This will accelerate antibody
discovery by enabling detailed and accurate immune complex structure predictions and structure-based
chemical liability detection at a high-throughput scale.
In Phase II, we first created an in silico human germline sequence library and used it to simulate the natural
V(D)J and VJ recombination events of the immune system, generating a new library of assembled antibody
sequences. To select antibody candidates that bound a chosen target, we developed a simulation algorithm in
which antibody candidates were docked against a chosen target protein. The 24 candidates with the best
predicted binding energy were converted to single-chain antibodies and propagated in CHO cells. Three
candidates were found to bind the target using native Western blots. The binding affinity and kinetics of these
three candidates were then measured by bio-layer interferometry. The tightest binding candidate was then
subjected to a form of simulated affinity maturation where individual site-directed mutations were ranked by their
predicted ability to enhance affinity for the antigen. Four out of five tested variants showed improved binding over
its parent using bio-layer interferometry.
The goal of our Phase IIB proposal is to build upon this success and further improve predictive capability by
incorporating unequaled algebraic mathematics and computational acceleration techniques to support the virtual
screening of tens of thousands of antibody sequences. For the first time in history, this will enable antibodies to
be selected for development by first modeling them from germline sequences using a “virtual immune system.”
Our ultimate intent is to deliver a complete antibody discovery pipeline that is powerful, accurate, produces fast
results, and yields lab-scale quantities of DNA and protein materials for the selected antibodies.

Public health relevance
Antibodies are invaluable biotechnology tools for diagnosing and treating human diseases; they have been used to detect drugs, toxins, hormones, or pathogens; perform tissue typing; suppress organ transplant rejection; and therapeutically treat viral infections, cancer, and autoimmune diseases. In this project, we will develop a pipeline to replace a large portion of costly, time-consuming experimental work required today in antibody drug discovery with a software pipeline based on improvement in and integration of protein structure prediction, protein-protein docking and protein engineering tools we currently provide to the market. Our proposed pipeline will be poised to accelerate antibody drug development and reduce costs of antibody drug discovery by 80 – 90%, literally revolutionizing the way antibody discovery and development is performed by biotech and pharmaceutical companies and third-party contract research organizations.